Intrarectal Immunization for a Barrier to Mucosal HIV Infection

Abstract
The impressive amount of data generated by experimental but mostly unsuccessful HIV/SIV vaccines
has led to the realization that protection will most likely requires 2 levels of barriers, the initial one at the
mucosal port of entry and if breached, a second set of systemic defenses. The capacity of humoral and cellular
immune responses in mucosal tissues to block or contain replication at the initial stage of virus transmission
may have a profound impact on the ability of a vaccinated host to resist infection, even when virus progresses
beyond the port of entry, allowing the systemic response more time to control or eradicate the incoming
pathogen.
We hypothesized that there are two features necessary for a successful vaccine: 1) A prolonged if not
life-long stimulation of the immune system with viral antigens to maintain “alert” immune responses; and 2) a
targeted immune response at the site of primary HIV replication. A vaccine approach that simultaneously
addresses these two issues would have the potential to achieve solid, long-term active protection.
To fulfill these requirements, we have developed an original strategy that successfully delivers a
vaccine to mucosal sites, providing antigen stimuli at recurrent intervals and elicit protective mucosal and
systemic immune responses. Our strategy leverages epithelial stem cells as permanent but non-expressing
source of viral antigen while their short-lived differentiated offspring express and present antigen to the local
immune system, along the mucosal surfaces of viral entry. Using a single cycle replicative-deficient SIV
(SIVsc) approach, which has been shown to be safe compared to traditional attenuated vaccines, we have
cloned the SIVsc genome under the control of the involucrin promoter (pINV-SIVsc), a terminally differentiated
keratinocyte specific promoter. When administered, the vaccine targets and transduces basal epithelial stem
cells from colorectal tissues. These cells then proliferate and differentiate into mature epithelial cells, triggering
SIV antigen expression via the promoter and leading to both direct and cross priming.
For this project, we propose: 1) To confirm and further improve the efficacy and safety profile of the
pINV-SIVsc vaccine via the colorectal route; 2) To visualize and optimize vaccine delivery, and investigate the
mechanisms of action underlying protection; and 3) Using our best optimized vaccine strategy, demonstrate
protection from virus acquisition and/or viral replication in vivo and determine the correlates of protection or
control against repeated low-dose intrarectal challenges with heterologous SIV.

Public health relevance
Narrative A vaccine that will be effective in preventing HIV infection and also control virus replication once the virus has taken hold, will require a dual barrier. The first one at the mucosal portal of entry for the virus to prevent or at least minimize the ability of the virus to create a beachhead and two at the systemic level where generalized immune responses are able to control virus that has succeeded in overcoming the first barrier. Our vaccine strategy targets renewable colorectal epidermal stem cells as a permanent source of antigen production which proliferate and elaborate the vaccine antigen along the phases of the reproductive cycle, providing repeated bouts of vaccine antigen presentation as the cells mature and cycle, leading to induction and maturation of humoral and cellular immune responses.